Functional assessment of atrial myosin mutations in familial atrial arrhythmia

PROJECT SUMMARY
Atrial fibrillation (afib) is a very common arrhythmia that affects up to 1 in 4 people over the age of 40 in their
lifetime, leading to major complications such as stroke and heart failure. There is growing evidence that a
proportion of afib cases result from an atrial cardiomyopathic process in which the fundamental contractile
function of the myocytes is altered, yet the fundamental mechanism is not well understood. Therapeutic
approaches to treating afib have largely focused on electrical modulation and structurally isolating the
abnormal rhythm, but this approach does not address the underlying pathology of the atria, and, unsurprisingly,
many patients have recurrence due to further progression of atrial remodeling. Therefore, it is critical to study
the fundamental contractile function in atrial cardiomyocytes to gain further insights into the mechanism of afib.
Here, we propose to study known genetic causes of afib in atrial cardiac myosin using the human recombinant
α-cardiac myosin system and state-of-the-art biochemical and biophysical assays we have developed with the
β-cardiac myosin platform. In Aim 1, we will construct the α-cardiac myosin heavy chain (MYH6), essential light
chain (MYL4), and regulatory light chain (MYL7), and compare their function with the β-cardiac myosin. We will
make several structural variations of the wildtype α-cardiac myosin using the heavy chain and light chains
above to perform a comprehensive analysis. In Aim 2, we will produce mutant α-cardiac myosin found in
familial afib cases with mutations in MYH6 (R721W, E933Δ). Some of these mutations (MYH6 R721W and
E933Δ) are seen in patients with hypertrophic cardiomyopathy when the same location in β-cardiac myosin is
mutated. We will determine their effect on myosin activity and overall sarcomere function.
Our experimental platform will be the first to comprehensively study the human α-cardiac myosin with various
mutations using the recombinant protein to carry out sophisticated biochemical and biophysical analysis. The
results from this study will lead to critical preliminary data for an R01 grant to further study the mechanism of
afib and will help develop novel therapies for this very common cardiovascular disease.

Public health relevance
PROJECT NARRATIVE Atrial fibrillation (afib) is the most common cardiac arrhythmia and is strongly associated with an increased risk of morbidity, including stroke and heart failure. This project will build a novel recombinant protein platform and use state-of-the-art biochemical and biophysical assays to study the effect of mutations in the atrial cardiac sarcomere genes (myosin) that result in familial afib to provide the mechanistic basis of the disease. This novel, much-needed perspective on the fundamental mechanism of afib from an atrial sarcomere function standpoint will add further therapeutic targets for pharmacotherapy.